Project 1: Assessment of the Health Effects of N-Nitrosamines and Development of Disease Mitigation Strategies

PROJECT SUMMARY/ABSTRACT – PROJECT 1
N-Nitrosamines include some of the most mutagenic chemicals known to humankind, and they are present at
and near Superfund Sites, in drinking water, in food and in drugs. Given their ubiquitous presence and potent
mutagenicity, research focused on N-nitrosamines is critical. What is needed are better ways to predict N-
nitrosamine-induced disease so that intervention strategies can be developed. A key barrier has been the
difficulty of studying long-term low-dose conditions. To overcome this challenge, Project 1 will create ‘canary in
a coal mine’ genetically engineered model (C-GEM) mice. The C-GEM mice will harbor genetic mutations in the
alkyladenine DNA glycosylase (Aag) and the O6-methylguanine methyltransferase (Mgmt), two of the most
important repair activities for NMDA-induced DNA damage. They will also harbor two transgenes for detecting
mutations (to be analyzed in collaboration with Project 2). C-GEM mice will be exposed to environmentally
relevant levels of NDMA, to be determined by Projects 3 and 4, and systems-level data (to be collected with
Project 2) will be merged by the Data Management and Analysis Core (DMAC) to create predictive biomarkers
and to better understand mechanisms of disease. Project 1 will also study a probiotic organism shown to
suppress NDMA-induced cancer. Finally, Project 1 will also create “Chem-Sense Cells,” a novel cell array-based
platform for screening environmentally relevant N-nitrosamines (to be identified by Projects 3 and 4) for their
DNA damaging potential. Specific Aim 1 is to leverage the C-GEM mice at a sensitive window of susceptibility
to reveal the long-term low-dose impact of NDMA administered under environmentally relevant conditions.
Specific Aim 2 is to use chemical-genetics to create Chem-Sense Cells as a novel biosensor for DNA damage
induced by N-nitrosamines present at Superfund Sites. Specific Aim 3 is to leverage the C-GEM mice to reveal
the biological mechanisms by which probiotics modulate mutation susceptibility via studies of systems-level
responses. Trainees will drive the research and will be supported by the Research Experience and Training
Coordination Core to ensure optimal professional development. With support from the Community Engagement
Core, Project 1 Leaders and trainees will also listen to and work with community members and tribes to develop
novel hands-on teaching curricula that explain key concepts in biology that underlie their research activities.
Importantly, Project 1 is part of a greater Systems Approach for the entire MIT SRP, for which interactions and
interdependencies (supported by the Administrative Core) give rise to impact that is not otherwise possible. This
includes using machine learning (in collaboration with the DMAC) to merge research results from this Project
with that of other Projects to gain a better understanding of risk. The Administrative Core also promotes the
dissemination of this Project’s innovative mouse and cell technologies, and it supports bringing research results
to the EPA and other stakeholders in order to maximize impact on public health.

Public health relevance
PROJECT NARRATIVE – PROJECT 1 N-nitrosamines are probable human carcinogens that are present not only at Superfund Sites, but also in the municipal water that is used by the Passamaquoddy Tribe, making it imperative that the NIEHS Superfund Research Program enable problem-based solution-oriented research on N-nitrosamines using cutting edge technologies. Genetic engineering will be used to create `canary in a coal mine' mice that can be used to detect the potential danger of conditions that people are experiencing (e.g., long-term low-dose exposure in drinking water), and by using chemicals that make cells sensitive to N-nitrosamines, we will be better able to predict the health consequences of N-nitrosamines, and so be in a better position to develop ways to prevent disease. Technologies that will be developed and results from these studies will be shared with stakeholders, including other scientists, community members, and organizations that oversee cleanup and environmental policies (including the EPA) in order to maximize the impact of this work on public health.